Administrative Core

ABSTRACT – ADMINISTRATIVE CORE (Lead: Sallie Permar, Weill Cornell Medicine)
The success of this renewal Program Project Grant and its scientific goals to assess both CMV immunity at the
maternal-fetal interface and vaccine candidates in a preclinical NHP cCMV model will require a highly efficient
and responsive Administrative Core (Admin Core). The Admin Core supports and manages the scientific
Projects and Cores, along with the guidance of a Scientific Advisory Board (SAB) and NIH Program staff,
ensuring steady progress toward meeting scientific milestones. The Administrative Core is essential for the
Program because it will provide programmatic management, centralized data management, and coordination
of financial and regulatory oversight, reducing the administrative burden of the individual Program components
while guaranteeing efficiency and synergy across all Projects and Cores.
Specifically, in Aim 1, the Admin Core will provide overall Program coordination, communications, and
supporting resources to ensure close collaboration and scientific progress. Aim 2 will centralize data
management to ensure scientific integrity and data sharing. Aim 3 will provide timely financial accounting and
regulatory oversight to ensure compliance with institutional and federal research guidelines.
By successfully completing its Aims, this Administrative Core will continue to ensure a unified research effort
and support for the Program's overall goal to develop additional vaccine strategies, including targeting viral
immune evasion proteins and eliciting local immunity at the maternal-fetal interface, that will be critical for
effective vaccination against congenital CMV.